Navigating the Transition to Adulthood: A Dual Language Mobile App for Latino Youth with ASD and Their Families

Project Summary/Abstract
This project aims to address the critical need for culturally adapted, evidence-based, and accessible
interventions to support Latino young adults with autism spectrum disorder (ASD) as they transition to
adulthood—a period fraught with challenges, including the loss of services and increased responsibilities.
Latinos face significant disparities in access to care compared to their White counterparts, particularly during
this pivotal life stage. To bridge this gap, the project will develop a bilingual mobile health (mHealth) application
(app) called ¡Iniciando! la Adultez, derived from the evidence-based ¡Iniciando! program, tailored for Latino
young adults with ASD across varying levels of support needs and their Spanish-speaking parents. Adults with
ASD feel more comfortable using online modalities of communication, including Artificial Intelligence (AI)
enhanced mHealth apps. Unfortunately, researchers have yet to develop a bilingual mHealth app for young
adults with ASD with varying support needs and their Spanish-speaking parents. Thus, by following the
Integrate, Design, Assess, and Share (IDEAS) framework, in Aim 1a the present study focuses on developing
and refining several bilingual mHealth app prototypes through collaborative brainstorming sessions with a
cross-sector team. The cross-sector team includes the UTHealth Houston McGovern Medical School
Information Technology UXS Innovation team and our Community Advisory Board (CAB), which includes
Latino young adults with ASD and their Spanish-speaking parents. The app will feature personalized lesson
plans, practice exercises, values and goals tracking, and an AI-driven “Coach” to support goal setting, with
wide accessibility on both iOS and Google Play platforms. Aim 1b involves rigorous accessibility, usability, and
quality testing of the mHealth app with Latino young adults with ASD and their parents. This will include alpha
and beta testing phases to ensure that the app meets the diverse needs of its users. Feedback from these
tests will guide iterative modifications to improve the app's content, features, and design into developing a fully
functional minimum viable product (MVP) of the mHealth app based on participant feedback, which will then
undergo final review by the CAB. Aim 2 will conduct a feasibility trial of the ¡Iniciando! mHealth MVP app with
Latino young adults with ASD and their parents to evaluate its usability, feasibility, and we will acquire metrics
(e.g., missing data, completion %) on measures of mental health, quality of life, and adaptive functioning. This
project is significant in its potential to offer a scalable and sustainable solution to the health disparities faced by
Latino young adults with ASD and their families. By providing an evidence-based, bilingual intervention as a
bilingual mHealth app, this project will contribute to reducing systematic barriers to therapy services, while
improving the quality of life and mental health of not only young adults with ASD but also their Spanish-
speaking parents This research aligns with the objectives of NICHD to enhance the transition to adulthood for
marginalized racial/ethnic populations through innovative interventions.

Public health relevance
Project Narrative This project seeks to develop a bilingual mobile health (mHealth) application (app), ¡Iniciando! la Adultez, designed to facilitate the transition to adulthood for Latino young adults with autism spectrum disorder (ASD) across varying levels of support needs and their Spanish-speaking parents. The mHealth app will serve as the primary platform for delivering the evidence-based, culturally and linguistically adapted ¡Iniciando! la Adultez therapy program. By increasing accessibility and promoting engagement, the ¡Iniciando! mHealth app is aimed at addressing the unique needs of Latino young adults with ASD across varying levels of support needs and their Spanish-speaking parents, particularly those residing in mental health professional shortage areas.